Leveraging Data to Action: Accelerating Emergency Department OUD Care by Improving Data Access and Infrastructure

Abstract
Data-driven evaluation and interventions have improved emergency care across an array of acute care
conditions including acute myocardial infarction, stroke and sepsis -- yet, similar systems to support and
advance emergency care for OUD are lacking amidst worsening patient outcomes. Our team completed
foundational data infrastructure work revealing gaps in ED data systems as well as identifying opportunities to
utilize the American College of Emergency Physician's Clinical Emergency Department Registry (CEDR) as a
national data backbone of over 1000 Emergency Departments (EDs) for OUD care. We propose to create new
data processes that will generate a collection of data products embedded within the CEDR ecosystem to
improve the timeliness, quality, accessibility, and usefulness of CEDR data to address the overdose epidemic.
To address these critical needs, we propose an acceleration project that will leverage our prior work
developing and refining electronic health record OUD data elements both within and outside of the CEDR
registry. This proposal will: 1) automate OUD-related data extraction from participating sites, 2) map ED data to
a standardized, scalable Observational Medical Outcomes Partnership (OMOP) Common Data Model (CDM)
3) Translate relational data within the CDM into research ready datasets with algorithmic extension of
important OUD concepts, and 4) create site and public facing ED OUD overdose prevention dashboards for
care improvement and surveillance. We hypothesize that the automation and integration of electronic health
record and administrative substance use disorder data into CEDR will improve the ability to identify
opportunities for improvement in ED OUD care and advance future research initiatives. During this study we
plan to assess digital readiness within CEDR and design an enhanced ED OUD data infrastructure
suitable for large scale observational research, support of future real-world clinical trials and benchmarking
dashboards (R61 phase) and develop and deploy an ED OUD digital infrastructure across clinical,
research and surveillance dimensions (R33 phase). Upon study completion, we anticipate an improved
national ED data registry using a standardized common data model, automated site level ED OUD dashboards
to guide near-real time local quality improvement initiatives, the existence of an independent ED OUD Registry
Research dataset, and a public facing, web based near-real time ED OUD care dashboard.

Public health relevance
Project Narrative We propose, in collaboration with the American College of Emergency Physicians (ACEP), to accelerate the development of emergency care data systems within a national data registry and advance national overdose prevention efforts. Our proposal will create a data system that automates extraction of data from emergency departments across the US to create research datasets and Emergency Department (ED) opioid used disorder (OUD) dashboards for quality improvement and a national web-based dashboard for public health surveillance. Our proposal will result in access to high quality, standardized, near-real time ED OUD care measure data that can improve care and outcomes across clinical, research and surveillance dimensions.